Exploring concepts in nanophotonics and metamaterials to create a 'super-scintillator' for time-of-flight positron emission tomography

Abstract
Positron emission tomography (PET) is a standard of care to molecularly characterize cancer and heart disease.
It is also a well-used research tool to visualize and quantify molecular pathways of disease in neurological
disorders. We propose to develop a metamaterial to create a “super-scintillator” for time-of-flight (ToF) PET. If
successful, this technology will substantially enhance the image quality and quantitative accuracy of PET and
open new roles for the modality in the management of disease. PET employs a radiolabeled molecular contrast
agent that is injected into the patient to probe the biological mechanisms of disease. This tracer accumulates in
the cells that express certain molecular signatures, enabling 3-dimensional visualization and quantification of
disease biomarkers. The tracer molecule is labeled by a positron emitter that for every decay results in the
emission of two oppositely directed 511 kilo-electron-volt (keV) annihilation photons. ToF-PET uses the arrival
time difference between the two photons in each pair to more accurately position the emission location along
PET system detector response lines, enhancing the reconstructed image signal-to-noise ratio (RISNR). RISNR
is an image quality metric that strongly correlates with lesion detection sensitivity and accuracy. The more precise
this time difference measurement, known as the coincidence time resolution (CTR), the better the RISNR. Any
boosts in RISNR can also be employed to reduce injected radioactive dose or scanning duration, increasing
patient safety or throughput in the clinic, respectively. The long-term goal for the proposed new scintillation
technology is <10 picosecond (ps) CTR, which is over 20-fold better than the best CTR (214 ps) achieved for a
state-of-the-art clinical ToF-PET system, enabling ~5-fold higher RISNR or ~25-fold lower injected dose or scan
time compared to that system. If successful, this capability would enable new applications for PET. Current PET
systems employ scintillation crystals, which are materials that convert 511 keV photon interactions in the crystal
into flashes of visible light. We propose to use nanophotonic techniques to create a metamaterial “super”
scintillator with vastly shorter rise time and decay time and greater light yield than all known PET scintillators,
enabling the >20-fold reduction in CTR proposed. The emergence of nanophotonics and metamaterials has
revolutionized photonics. Nanostructured materials provide considerable control over internal electromagnetic
fields, enabling highly unusual optical properties not found in standard materials. This exciting investigation will
have tremendous impact by both introducing a new technology, metamaterials, to the field of biomedical imaging,
and by achieving breakthrough performance levels in PET imaging, that, if successful, will greatly expand PET’s
capabilities for characterizing disease, as well as enable new roles for PET in disease management.

Public health relevance
Narrative We propose to explore advances in nanophotonics and metamaterials to create a new “super” scintillator technology for time-of-flight positron emission tomography (ToF-PET) with a goal of increasing the reconstructed image signal-to-noise ratio (RISNR) by ~5-fold over the state-of-the- art clinical ToF-PET systems, in order to greatly enhance PET image quality and accuracy and create new diagnostic and therapeutic roles for PET. We propose to create a new metamaterial using novel self-assembling nanofabrication techniques that can enhance the electromagnetic properties of scintillators to realize a “super” scintillator that will have vastly superior brightness, rise time, and decay time than all known PET scintillators, enabling detectors with 10 ps coincidence time resolution (CTR), compared to 214 ps CTR for the newest state-of-the-art ToF- PET clinical system that employs conventional scintillation crystals.